Elucidating the role of tumor cell-intrinsic hypoxia inducible factor (HIF)-1α and HIF-2α pathway activation in tumor immune evasion

Project Summary/Abstract
This is an application for a K08 Career Development Award for Jonathan Trujillo, MD PhD, who is a clinical
instructor in the Section of Hematology/Oncology at the University of Chicago. He is building a career as a
physician-scientist focused on identifying immunotherapy resistance mechanisms to improve outcomes for
patients with cancer. His proposed project will determine the role of tumor cell-intrinsic hypoxia-inducible factor
(HIF)-1α and HIF-2α activation in mediating tumor immune evasion and immunotherapy resistance. Cancer
remains the second leading cause of mortality in the United States in spite of intensive treatments. Immune
checkpoint inhibitors have shown impressive and durable clinical responses in some patients, yet the majority of
patients fail to respond to these immunotherapies. Emerging data indicate that increased hypoxia-induced
signaling, which is mediated by the hypoxia inducible factor (HIF)-1α and HIF-2α pathways, within the tumor
microenvironment is associated with reduced T cell-based inflammation and resistance to anti-PD-1 blockade.
The impact of tumor cell-intrinsic HIF-1α and HIF-2α activation on the anti-tumor T cell response has yet to be
determined. The overarching hypothesis of this proposal is that cancer cell-intrinsic HIF-1α or HIF-2α activation
leads to defective T cell priming and ineffective T cell infiltration, thereby promoting tumor immune evasion and
immunotherapy resistance. Novel genetically engineered mouse models of melanoma with conditional
expression of a stabilized variant of HIF-1α or HIF-2α have been generated to determine whether cancer cell-
intrinsic HIF-1α or HIF-2α activation limits the degree of T cell accumulation within tumor tissue and reduces
tumor sensitivity to immune checkpoint inhibitors. The proposed studies will determine whether HIF-1α or HIF-
2α functions by impairing T cell priming and/or by limiting effector T cell infiltration and function in the tumor
microenvironment. Mechanistic studies will be performed to determine whether HIF-1α or HIF-2α pathway
activation results in failure to accumulate and activate dendritic cells required to generate T cell responses,
failure to upregulate chemokines needed for DC or T cell recruitment, aberrant tumor vasculature which can limit
T cell infiltration, or induction of immunosuppressive factors that can impair T cell responses. These data may
provide rationale for the combination of novel HIF inhibitors and immune checkpoint blockade therapy. Dr. Trujillo
has devised a career development plan to accomplish the following goals during this award: 1) develop expertise
in immunologic and genomics techniques and mouse models of anti-tumor immunity; 2) become proficient in
bioinformatics; 3) to expand knowledge in renal cell carcinoma with a focus on immunotherapeutics and novel
HIF inhibitors. He has developed a strong mentoring committee led by his primary mentor Dr. Thomas Gajewski,
an internationally renowned expert in cancer immunology. Thus, upon completion of this proposal, Dr. Trujillo
will emerge as an independent physician-scientist focused on cancer immunology and clinical immunotherapy.

Public health relevance
PROJECT NARRATIVE Cancer remains the second leading cause of mortality in the United States. While immunotherapies, including checkpoint inhibitors hold great promise, most patients do not respond to immunotherapy and resistance mechanisms are incompletely defined. This proposal will use genetic murine tumor models to determine the mechanistic role of tumor cell-intrinsic hypoxia inducible factor (HIF)-1α and HIF-2α activation in impairing the anti-tumor T cell response within the tumor microenvironment and promoting immunotherapy resistance.